Skin-interfaced triboelectric sensors continuously monitor worker forceexertions to prevent workplace injuries

Abstract
Despite advances in automation, manual material handling (MMH) tasks continue to be commonplace in the
workplace. To design and control the high burden of musculoskeletal disorders (MSDs) during MMH tasks,
several assessment tools have been proposed to monitor injury risk factors such as posture, repetition and force.
However, several fundamental limitations of current tools affect their effectiveness in controlling injury risk
factors. First, tools currently used in practiced are typically cross-sectional and observer-based. These manually
observed snapshots of the jobs are insufficient for capturing the complex exposures (e.g., varying frequencies,
loads, hand-load couplings) that workers experience daily in MMH. Second, worker force exertion is a key causal
factor for MS injuries, and unlike repetition and posture, force exertions are “invisible” such that even trained
ergonomists have difficulty assessing without interfering with the workers or the hand-material interfaces. Finally,
current tools are not practical at scale for capturing the individual exposures of every worker at every task (e.g.,
time and labor cost of trained analysts to directly observe or videotape the workers).
This proposal aims to address the need for automated systems for predicting workers’ hand, wrist, and forearm
injury risk in manual material handling (MMH) tasks. We propose innovative low cost, sensitive, and scalable
triboelectric glove system with advanced deep-learning techniques. The proposed tool will be the first all-
in-one glove system that can automatically assess all metrics required for the American Conference of
Governmental Industrial Hygienists (ACGIH) Threshold Limit Value (TLV) for Hand Activity Level (HAL).
Three studies are proposed: 1) material engineering to produce reliable triboelectric sensors at scale, 2) iterative,
user-centered design of multi-modal glove sensors for MMH, 2) experiments to train artificial intelligence models
for predicting HAL TLV, and 3) demonstration of the technology in real work environments. The expected
immediate outcomes of this work will result in a novel system that can impact two critical challenges in
managing workplace hand/wrist MSDs: 1) scalable, automated assessment methods that can continuously
monitor the high varied MMH tasks and 2) enable practitioners to assess the “invisible” force exertion risk factor
that current relies on techniques such as force matching or manually weighing objects. This work aligns with
NIOSH’s overall strategic goal of reducing occupational musculoskeletal disorders and have cross-sector
impacts, specifically the immediate goal of reducing musculoskeletal disorders with emerging technologies.

Public health relevance
Project Narrative Despite advances in automation, manual material handling (MMH) tasks continue to be commonplace in the workplace. Poorly designed and controlled MMH tasks present a substantial health and safety burden in the United States (US) and worldwide. The proposed research will develop novel materially engineered triboelectric wearable and real-time based system that can be widely implemented for 1) accurately identifying both hand activity level and hand force exertions during MMH task performance and 2) predicting the worker threshold limit values (TLV) for upper extremity injury risk during repetitive MMH tasks.